Developing next-generation high-content image-based genetic screens for multi-omic spatial phenotypes

Project Summary/Abstract
Spatial organization of the genome, nucleome and transcriptome is key to their control of many essential
genomic and cellular functions. Yet existing tools limit our ability to identify regulators of these spatial
organizations. We are developing a high-content, image-based CRISPR screen to discover three-dimensional
(3D) genome regulators, a first-in-kind technology to uncover the regulatome of 3D genome architectures
across multiple length scales. Our proof-of-concept screen targeting hundreds of candidate regulators
identified many novel chromatin organization regulators. The goal of this application is to advance our
technology to develop a highly-efficient, large scale, and multi-omic screening platform to discover the
molecular regulators of the spatial genome, nucleome and transcriptome. In Aim 1, we will develop a
generalizable, large scale screening platform compatible with in situ spatial omics techniques. In Aim 2, we will
develop multimodal detection and perturbation methods for comprehensive large scale screens of 3D
nucleome regulators. In Aim 3, we will develop integrative methods for large scale screens of spatial
transcriptome phenotypes to allow efficient discovery of the regulatory mechanisms of subcellular RNA
transport and localization. We expect that these proposed developments will provide the research field with
brand-new, broadly applicable technologies for mechanistic studies of the spatial genome, nucleome and
transcriptome in a wide range of biomedical contexts.

Public health relevance
Project Narrative The spatial organization of DNA and RNA in our cells regulate important genomic functions such as gene expression and localized protein production in specific sub-cellular regions, and the spatial organization of DNA and RNA is regulated in turn by upstream regulatory mechanisms. Yet our understanding of what regulators control the spatial organization of DNA and RNA is far from complete, due to a lack of large-scale discovery technologies. This study will invent a new technology platform that will enable highly efficient discovery of upstream regulators of the DNA and RNA organization, which will help elucidate and engineer the spatial axis of molecular biology in health and disease.